The Impact of Morning Insulin Delivery on Hepatic Glucose Metabolism Later in the Day

PROJECT SUMMARY
The 2nd meal phenomenon describes the substantial improvement in glucose tolerance that occurs during a
subsequent identical meal (e.g. improved glycemic response at lunch vs. breakfast). We have shown that 1)
hyperinsulinemia is the essential factor during the 1st meal, and 2) the enhanced glycemic response during the
2nd meal is due to increased hepatic glucose uptake and glycogen storage. This proposal seeks to elucidate the
mechanisms by which morning (AM) hyperinsulinemia enhances the liver’s subsequent response. These studies
will be executed using complex metabolic clamping experiments performed in the multi-catheterized conscious
dog model. Aim 1 will determine the impact of the AM insulin route of delivery (i.e. we will compare the effect of
portal vein insulin infusion, as occurs with endogenous insulin secretion, vs. peripheral insulin delivery, as
typically occurs with therapeutic treatment for individuals with insulin-dependent diabetes). Secretion of insulin
into the portal vein results in exposure of the liver to 3-times more insulin than the rest of the body. Intravenous
(peripheral) insulin infusion eliminates that gradient, exposing the liver to relative insulin deficiency. We
hypothesize that AM hyperinsulinemia generated by peripheral (vs portal vein) insulin delivery will severely impair
the liver’s amplified afternoon (PM) meal response. This is highly relevant to the treatment of patients with insulin-
dependent diabetes since most of the currently available insulin therapies involve delivery by the peripheral route
(e.g. subcutaneous insulin injection). Previous work has shown that 3 factors are primarily responsible for
regulating hepatic glucose uptake: 1) insulin action, 2) the effect of glucose itself (glucose effectiveness), and 3)
the portal glucose signal of neural origin, generated when glucose concentrations are greater in the portal vein
compared to the hepatic artery, such as occurs when glucose is absorbed from the gut during a meal. Aim 2 will
investigate which of these factors are contributing to the enhancement of hepatic glucose metabolism during the
2nd meal phenomenon. We hypothesize that AM hyperinsulinemia primes the liver for greater PM glucose uptake
and storage via an enhancement of insulin action in the afternoon. The proposed studies are significant because
they will provide a more thorough understanding of the impact of AM feeding on hepatic glucose metabolism
during the remainder of the day, leading to new ways to improve glycemic management in individuals with
impaired glucose tolerance and diabetes. The training plan will be carried out with the support of the excellent
resources that the Cherrington lab and Vanderbilt University have to offer. The Cherrington lab has over 50 years
of experience with the techniques outlined in this proposal. Paired with the career development opportunities
that The Biomedical Research Education and Training office provides for biomedical research graduate students
and the longstanding history of excellent physiology and diabetes research conducted in the Department of
Molecular Physiology and Biophysics, Ms. Waterman is placed in the ideal environment to successfully obtain
the necessary expert training and skill acquisition to shape her into an independent researcher.

Public health relevance
PROJECT NARRATIVE Diabetes affects nearly half a billion people worldwide and is correlated with an increased risk for cardiovascular disease, the leading cause of death globally. The proposed studies will provide novel insight into hepatic glucose handling following sequential meals to provide a more thorough understanding of the second meal phenomenon that can then be utilized to devise strategies aimed at improving glycemic management over a 24h period. This is incredibly important for individuals with insulin-dependent diabetes, as meal composition and timing can be tailored as a means of lifestyle intervention to maximize hepatic glycogen reserves, which will act as a first line of defense against hypoglycemic episodes.